Long-Term Health Impact of Vietnam Era Service: Examining Gender Differences in Risk of Mortality and Chronic Disease

Background: Despite increasing evidence of the health impact of exposure to traumatic stress during wartime
for veterans, less is known about gender differences in long-term health risks, including risks for chronic
disease and early mortality. Given that veteran status can be an important influence on later health, it is
important to advance understanding of what are likely to be gender-specific effects, as much of what is
currently known about veterans’ long-term health is based on male veteran samples. To better tailor clinical
services for veterans, more information is needed on gender differences in the implications of military service—
including the effects of warfare-related exposures, as well as experiences disproportionately facing deployed
women, such as military sexual trauma (MST), and their mental health sequelae—for long-term health
outcomes, especially chronic disease morbidity and all-cause and cause-specific mortality, including suicide.
Study Design: The proposed retrospective research will overcome existing gaps in the literature related to
representing older women veterans and examining long-term health risk by leveraging data from two national
cohorts of Vietnam Era (VNE) veterans: HealthViEWS (CSP 579; N=4,219), a study of VNE women veterans,
and the Veteran Health Study (CSP 569; N=5,598), a study of male VNE veterans. Leveraging and building
directly on these two VA CSP studies, the objective of this project is to examine gender differences in the
impact of military service, including warfare-related exposures and MST, and mental health sequelae—
posttraumatic stress disorder (PTSD), major depressive disorder (MDD), generalized anxiety disorder (GAD),
and substance use disorder (SUD)—on later-life health outcomes, with a focus on cardiovascular disease
(CVD), cancer, and other chronic conditions and early mortality risk. Both CSP studies used a mail survey to
collect data on demographics, military experiences, health outcomes, and psychosocial factors, and a
telephone interview to diagnose psychiatric disorders. In addition to leveraging these important VA data, vital
status records on CSP participants will be obtained via the National Death Index (NDI). This study will also
account for salient military service characteristics and later-life psychosocial factors, such as health behaviors,
social support, and suicidal ideation. Gender comparisons in the weighted prevalence of health outcomes will
be conducted, and associations will be tested using regression-based models, including gender-stratified
structural equation modeling (SEM) to examine gender differences in risk for long-term health outcomes.
Clinical Implications: As the number of veterans age 65 and older accessing VA healthcare is expected to
rapidly increase over the next 10-20 years, it is crucial to advance understanding of aging veterans’ health and
clinical care needs in the context of their military experiences. In addition to directly targeting the VA Women’s
Health priority area, this project is responsive to CSR&D calls for research that advances understanding of
PTSD and commonly occurring co-morbidities (i.e., MDD and SUD), as well as suicide and diseases with a
high healthcare burden in the veteran population, such as CVD. This project’s focus on gender comparisons
represents a critical step forward in the understanding of the lasting effects of military service for veterans, as
the vast majority of studies on older veterans to date have focused on men, and gender comparisons of long-
term health risk and associated implications for clinical care have rarely been conducted. Yet women’s
experiences in the military are distinct from men’s experiences, and women veterans may have different
clinical care needs than their male counterparts. This project’s ultimate objective is to provide actionable
information that can be disseminated to VA clinical services to target the unique needs of aging female and
male veterans, while also informing preventive care to maximize long-term health for veterans across eras.

Public health relevance
This study is responsive to the identified need for more information on the health and corresponding healthcare needs of women veterans, as well as recognized gaps in the understanding of the gender-specific impact of military service on female and male veterans’ long-term health. Given that trauma exposure can have negative and lasting effects on health, traumatic stress and mental health sequelae (i.e., PTSD, depression, anxiety, and substance abuse) are a public health concern that is of particular relevance to VA clinical services. To date, risk models linking military service with health outcomes have been understudied in older populations, and especially in older women. Combining data from two important VA cooperative studies—the Health of Vietnam Era Women’s Study and the Veteran Health Study—will provide the foundation for key insights into gender differences in the long-term health effects of military service, including risk for cardiovascular and other chronic disease morbidity, as well as mortality due to these and other causes, including suicide.